Adipose Tissue and Metabolic Health

ABSTRACT Support is requested for a Keystone Symposia conference entitled Adipose Tissue and Metabolic Health, organized by Drs. Jacqueline M. Stephens and Antonio J. Vidal-Puig. The conference will be held in Keystone, Colorado from February 6-9, 2022. Like the Obesity and Type 2 epidemics, our understanding of adipocytes and adipose tissue biology continues to expand. Substantial research advances have led to new insights into the contributions of adipose tissue to normal physiology and obesity-related complications, which places adipocyte biology at the epicenter of a global pandemic of metabolic diseases. This Keystone Symposia conference will consider the locations and functions of different adipose tissue depots, as well as recent studies that use stable isotopies to provide insight into how formation and turnover of adipocytes contributes to metabolic disease. The secretory capacities of adipose tissue will be covered in several different sessions including Influences of Adipose Tissue Immune Cells and New Adipose Tissue Products-Exosomes and Lipid Containing Vesicle. Arguably one of the most significant discoveries in the last two decades of adipocyte research, is that adipocytes not only release endocrine hormones, but fat cells and adipose tissue secrete a variety of effectors, including exosomes, miRNA, lipids, inflammatory cytokines, and peptide hormones that act in both paracrine and endocrine capacities to impact local and systemic metabolic responses. Hence, talks on inflammation, metabolically healthy fat, and adipose tissue expansion are also covered in this program. In addition, this conference will also include a session on alternate models (flies, fish, and worms) that are currently used to study adipose tissue and metabolic diseases. Overall, the program for this conference will be highly informative to research scientists in academia and industry who have an interest in the contribution of adipose tissue to metabolic disease states.

Public health relevance
PROJECT NARRATIVE The study of adipose tissue has evolved over the years to take center stage in the etiology of most metabolic diseases. Substantial research advances have led to new insights into the contributions of adipose tissue to normal physiology and obesity-related complications. The program for this conference will be highly informative to research scientists in academia and industry who have an interest in the contribution of adipose tissue to metabolic disease states.